Task A29: In vitro screening for antifungal activity against fungal disease pathogens

This contract provides in vitro testing of potential anti-fungal agents, efficacy to combat the effects of toxins produced by fungi, maintenance of fungal and toxin stocks, and the development of related assays.